STROKE PREVENTION TRIAL IN SICKLE CELL ANEMIA

Mutlicenter study designed to test the hypothesis that first time stroke in children with sickle cell disease can be reduced by at least 70% using chronic tranfusion in children found to be at highest risk by transcranial doppler.